Reducing African Americans' Alzheimer's Disease Risk Through Exercise-MCI Cohort (RAATE-MCI)

Project Summary
Alzheimer’s disease is steadily increasing in prevalence, with a devastating public health impact. The
prevalence of Alzheimer’s Disease is higher in African Americans compared to white Americans, thereby
constituting a health disparity. Individuals with mild cognitive impairment (MCI) are at increased risk for
progressing to dementia, including AD dementia. Interventions that prevent Alzheimer’s disease or change the
course of cognitive decline associated with Alzheimer’s disease are needed. Most older adults do not achieve
recommended levels of physical activity, and this includes African Americans. Regular physical activity has
proven to be a safe and effective means to enhance cognitive function in older adults with MCI. Therefore, our
study is focused on physical activity promotion, a potent approach to modifying multiple neurobiological
pathways implicated in Alzheimer’s Disease. We evaluate exercise benefits among elderly African Americans,
who are understudied and in whom the natural course of neurodegeneration, exercise effects on
neuroprotection and neurodegeneration, and resulting clinical phenotypes may differ. A large body of existing
data suggests that exercise improves cardiovascular and cerebrovascular functioning, and thus has the
potential to enhance perivascular clearance of amyloid and reduce chronic brain tissue ischemia, among other
beneficial effects. At the same time, chronic exercise has been shown to increase central levels of
neurotrophic factors, which in turn promote protection against Alzheimer’s Disease neurodegeneration
pathways via a variety of mechanisms. While physical activity interventions have been shown to have positive
effects on these factors and on resultant cognitive functioning in older adults, nearly all interventions have had
a negligible representation of African Americans. Prior data suggests that African Americans enter their elderly
years against a backdrop of different lifespan exposures to a variety of factors relevant to neuroprotection and
neurodegeneration, including cardiovascular risk, exercise, diet, and education. In addition, prior data
suggests that the key genetic risk factor for Alzheimer’s Disease (APOE) may have differing consequences for
Alzheimer’s Disease risk among African Americans, and other genetic differences (i.e. leucocyte telomere
length) have the potential to influence the brain benefits of physical activity in this community. We will utilize a
randomized clinical trial to addresses these questions. Participants will be randomized into a physical activity
promotion intervention or an active control group for 52 weeks. We will recruit a population with MCI. We will
assess cognitive function, brain structure and function, circulating hormones, neurotrophic factors, objectively
measured physical activity, cardiorespiratory fitness, sleep parameters, and telomere length. Our study will
take the first step toward understanding whether the hypothesized benefits of exercise for the brain carry over
to elderly African Americans with MCI.

Public health relevance
Narrative African American adults have two times the risk of developing Alzheimer’s Disease compared to other ethnic groups. Regular physical activity is promising for reducing risk of Alzheimer’s Disease, but there is very little data on this question in African Americans. The current study (called “RAATE-MCI”) will determine if regular physical activity conducted over a year will reduce risk factors for developing Alzheimer’s Disease in older African American adults with mild cognitive impairment. We will assess participant’s brain functioning, brain structure, memory, chromosomes, and the contribution of plaques in the brain on outcomes.